CANNABIS IMPAIRMENT DETECTION APPLICATION (CIDA) (T163). SBIR PHASE II. POP: 9/20/2019-9/19/2021. N44DA-19-1218.

Under this Small Business Innovation Research (SBIR) Phase I project, Research Topic 163, the Contractor will develop a portable, easily applied system incorporating a neuropsychological test protocol to detect cannabis impairment.